Fogarty African Bioethics Post-Doctoral Training Program

PROJECT SUMMARY/ABSTRACT
The Fogarty African Bioethics Post-Doctoral Fellowship Program is an 18-month long advanced bioethics
postdoctoral training program for scholars from sub-Saharan Africa who hold a bioethics-related PhD. This D43
renewal is a collaboration between Johns Hopkins University (USA), Makerere University (Uganda), and
University of Oxford (UK). The program will deepen trainees' academic and scholarly skills in bioethics, foster
leadership capacity, and create individual and group bioethics networking opportunities. Its substantive focus
is in the area of global health ethics, with an emphasis on global infectious disease ethics and advanced
research ethics. Ten postdocs will spend modular, dedicated time in each of the above institutions, and in
their home institution, completing individual and collaborative scholarly writing, organizing a global health
ethics leadership project, and engaging in global bioethics professional networks. The first 4.5 months of
training will be hosted at the Johns Hopkins Berman Institute of Bioethics completing courses and seminars;
preparing bioethics manuscripts; engaging in team science; interacting with a vibrant community of bioethicists;
and drafting a formal plan for their leadership project. Fellows will spend one month at the University of Oxford
Ethox Centre where they will learn different approaches to bioethics, make additional professional connections,
receive additional mentoring, become integrated into the Global Health Bioethics Network, participate in the
well-attended Oxford Global Health & Bioethics International Conference, and work with faculty and fellows to
organize a workshop on emerging topics in global health ethics. During the 11.5 months at home, fellows will
focus on strategy, implementation, and management of their leadership project while participating in biweekly
mentoring sessions and presenting their works-in-progress to colleagues in their home institutions. They will
join quarterly global health ethics leadership webinars – a resource that will be shared widely – and engage
several times virtually with program alumni and Africa-based bioethics scholars to organize an African
Bioethics Scholars Network (ABSN). Fellows will spend the final month of the fellowship at Makerere University
(Uganda), where the core activity will be hosting a hybrid meeting of the ABSN, during which fellows will
present research and leadership projects and interact with others they invite for engagement. They will then
participate in the Annual National Research Ethics Conference (ANREC), hosted annually by the Ugandan
National Council for Science and Technology; network with the community of bioethics faculty at Makerere;
and teach Fogarty trainees. The “glue” of the fellowship will be consistent mentoring, support, and feedback for
every postdoc by program faculty and local mentors. By leveraging our experience and longstanding
commitments to advanced bioethics training, along with well-developed institutional relationships, we propose
this highly collaborative post-doctoral program to further advance the analytic thinking, visibility, leadership
capacity, and professional networks of the top doctorally-trained bioethics scholars from sub-Saharan Africa.

Public health relevance
The Fogarty African Bioethics Post-Doctoral Fellowship Program (FAB-PDF) is an 18-month advanced bioethics training collaboration between Johns Hopkins University (USA), Makerere University (Uganda), and University of Oxford (UK) providing 10 African PhD-level scholars with coursework, scholarly writing projects, leadership development, and professional networking in global infectious disease ethics and advanced research ethics. The program develops advanced bioethics expertise essential for ethical conduct and oversight of NIH-funded research in sub-Saharan Africa – expertise that is grounded in the local contexts where such research occurs and that supports the generation of critical knowledge on diseases, treatments, and interventions directly relevant to protecting and improving the health of Americans. It ensures robust, contextually informed evaluation of emerging ethical challenges that must be addressed for U.S.- and internationally-sponsored health research to meet the highest ethical standards.